Dynamic prediction incorporating time-varying covariates for the onset of breast cancer

PROJECT SUMMARY
Accurate assessment of risk is a top priority in oncology due to the population burden of cancer. Breast cancer
is the leading cancer diagnosis among women worldwide and accordingly has the longest and broadest focus
on risk prediction. Most traditional prediction models only utilize baseline factors known to be associated with
breast cancer risk. More recent models expand to place greater emphasis on genomic risk factors. However,
the predominant move of adding genomic risk markers incorporates a measure that is invariant to time (based
on SNPs) and do not necessarily solve the challenge of improving breast cancer risk classification. The
intrinsic heterogeneity between and within patients over time are reflected in part, by the time-varying covariate
trajectories, which may provide important information for the prediction of breast cancer risk. The accumulation
of cancer risk over life, well documented for breast cancer, is ideally suited to methods that incorporate time-
varying covariates. Theobjective of this proposal is toprovide novel statistical models that can incorporate
patient heterogeneity in a personalized, dynamic manner leading to a more accurate risk prediction scheme.
The proposed algorithms encompass innovative functional approaches to comprehensively characterize the
changing pattern of the longitudinal trajectories by a set of outcome-independent/unsupervised and outcome-
dependent/supervised features. The set of individual-specific features will contain information on the observed
time-varying `pattern' rather than one-time exposure in existing methods, leading to a higher predictive power.
The dynamic prediction models will be built in a stepwise fashion, starting with a single time-varying covariate,
and extended to the multivariate settings, to accommodate multiple time-varying covariates. The proposed
methods will be applied to the Nurses' Health Study and further assessed externally in the Mayo
Mammography Health Study. All of the proposed methods will be accompanied with user-friendly open-source
software.

Public health relevance
PROJECT NARRATIVE Theobjective of this proposal is toprovide novel statistical models that can incorporate patient heterogeneity in a personalized, dynamic manner leading to a more accurate risk prediction scheme. The proposed project, although motivated by, but not limited to, breast cancer, willbe applicable to a broad range of applications from preventionto treatment and survivorship.